Pharmacological characterization of novel opioid drugs

Summary- Significant progress was made and numerous articles were published. Importantly, a comprehensive review article describing the pharmacology of the kappa opioid agonist Salvinorin A was published. This scholarly review integrates our research findings with the current knowledge about the molecular mechanism and pharmacology of Salvinorin and related kappa opioids. Neuropharmacology of the naturally occurring kappa-opioid hallucinogen salvinorin A. (2011) Pharmacol. Rev. 63:316-347. Salvia divinorum is a perennial sage native to Oaxaca, Mexico, that has been used traditionally in divination rituals and as a treatment for the semimagical disease panzn de borrego. Because of the intense out-of-body experiences reported after inhalation of the pyrolized smoke, S. divinorum has been gaining popularity as a recreational hallucinogen, and the United States and several other countries have regulated its use. Early studies isolated the neoclerodane diterpene salvinorin A as the principal psychoactive constituent responsible for these hallucinogenic effects. Since the finding that salvinorin A exerts its potent psychotropic actions through the activation of KOP receptors, there has been much interest in elucidating the underlying mechanisms behind its effects. These effects are particularly remarkable, because 1) salvinorin A is the first reported non-nitrogenous opioid receptor agonist, and 2) its effects are not mediated by the 5-HT(2A) receptor, the classic target of hallucinogens such as lysergic acid diethylamide and mescaline. Rigorous investigation into the structural features of salvinorin A responsible for opioid receptor affinity and selectivity has produced numerous receptor probes, affinity labels, and tools for evaluating the biological processes responsible for its observed psychological effects. Salvinorin A has therapeutic potential as a treatment for pain, mood and personality disorders, substance abuse, and gastrointestinal disturbances, and suggests that nonalkaloids are potential scaffolds for drug development for aminergic G-protein coupled receptors